Development of Tissue Engineered Neuromuscular Interfaces from GalSafe Neurons

PROJECT SUMMARY
Major peripheral nerve injury (PNI) is classified as an injury with a long defect (≥3cm) or occurring proximally,
requiring long regenerative distances of the host nerve to distal structures (distal nerve, target muscle, etc.).
These features result in minimal, if any, functional regeneration as the distal nerve and muscle often degenerate
before the host nerve is able to reinnervate these structures due to inherently slow regeneration rates. Since
current standard clinical practices delay repairing nerve injuries until the patient (in cases of polytrauma) or the
injury site is stabilized, functional recovery is often extremely limited. In order to maintain the innervation
capability of nerves and muscles following injury, the team at Axonova Medical has developed a proxy for these
degenerating axons to maintain or “babysit” the distal structures until the host axons are able to reinnervate the
distal targets. This product, the micro-tissue engineered nerve graft (µTENG), which acts as a tissue engineered
neuromuscular interface, consists of axon tracts spanning a discrete population of neurons within a hydrogel
column. Notably, the diameter of µTENGs is designed to be on the scale of micrometers, making them injectable
to facilitate incorporation into current standard of care practices in the clinic. In pre-clinical rodent studies,
µTENGs have been seen to extend axons into distal structures post implantation, resulting in babysitting of distal
nerve, therefore keeping the muscle receptive to eventual host axon reinnervation.
Previously, larger laboratory-grade µTENGs have been fabricated using primary rat and porcine neurons within
an agarose microcolumn. Through the Phase I studies, a clinically relevant product was developed and
characterized using GalSafe® neurons within a chitosan microcolumn, with a 200-200µm diameter. Through the
successful completion of this proposal, we will advance µTENGs to the clinic by establishing current good
manufacturing practices (cGMP)-like manufacturing, critical quality attributes, release criteria, and an effective
dosing paradigm. We will also complete in vivo studies in a porcine model of PNI to determine the efficacy of
µTENGs to promote functional recovery following delayed repair. Successful execution of these studies will
accelerate preclinical safety and efficacy studies and will be incorporated in Axonova’s IND application. Overall,
µTENGs hold promise in transforming the field of nerve repair by significantly increasing the clinical window for
PNI repair.

Public health relevance
PROJECT NARRATIVE Peripheral nerve injury (PNI), especially those that are long defects or proximal injuries requiring long regenerative distances often result in poor functional recovery, leading to a drastic decrease in quality of life. Current clinical practices take nearby healthy nerve and attach it to injured nerve or it’s innervated muscle in order to protect loss of function. To address this need, we have developed a potentially transformational approach to maintain the distal structures and the pro-regenerative environment using implantable micro-tissue engineered nerve grafts (µTENGs) that act as tissue engineered neuromuscular interfaces so that effective reinnervation can occur, even in cases where repair of the damaged nerve is delayed, thus leading to increased functional recovery.